Proteoglycan Metabolism During Cardiac Valve Development and Disease

Summary: Approximately 1.5% of individuals have a Bicuspid Aortic Valve (BAV) that can result in insufficient
blood flow and organ damage (1, 2). A BAV is also an independent risk factor for ascending aortic wall
complications that can lead to rupture and sudden death. However, the cell and molecular basis for the BAV is
unknown. Even basic aspects of BAV formation are undefined due to contributions from multiple cell lineages
and a lack of highly penetrant viable BAV mouse models. Dysfunctional aortic valves exhibit massive
accumulation of the extracellular matrix (ECM) proteoglycans versican (Vcan) and aggrecan (Acan) (3-7) but the
origin and consequence of excess proteoglycans is largely unknown. Since proteoglycans are highly stable,
abundance is regulated primarily by proteolytic degradation which led us to investigate a role for proteoglycan
cleavage. We discovered that loss of a single ECM proteoglycanase, Adamts5, results in enlarged aortic valves
with ascending aortopathies (100%). These defects co-localize with substantial increases in Vcan and Acan in
the affected tissues (8-10) that mirror the human condition. Mechanistically, in Adamts5-/- aortic valve primordia
with excess Vcan there is a reduction of pSmad2, and when Smad2 is reduced further by generating Adamts5-/-
;Smad2+/- mice, there is a high penetrance of BAV (75%), much higher than seen in other mouse BAV models.
The objective of this proposal is to utilize the viable Adamts5-/-;Smad2+/- mice that exhibit a high percentage of
BAV, to define morphological events, cell behaviors and factors that when disrupted contribute to BAV formation.
Since excess Vcan is a hallmark of dysfunctional and diseased valves, use of a model with mutations that impact
the control of Vcan content, may shed light on how proteoglycan metabolism is regulated in development and
may also give insight into disease. Experiments test the hypothesis that ECM Vcan cleavage coordinates
mesenchymal cell behaviors and myocardial cell contributions that are required for the tricuspid morphology of
aortic valves. The hypothesis is tested in two aims: Aim 1 tests the impact of altered Vcan cleavage on
mesenchymal cell lineage behaviors that are required for aortic valve formation. Our preliminary data show that
loss of Vcan cleaved fragments and excess intact Vcan, disrupted lineage-specific patterning in the developing
aortic valves of the BAV Adamts5-/-;Smad2+/-mice. A combination of ex vivo, and in vivo approaches will decipher
the lineage-specific cell behaviors, and guidance factors that are dependent on Vcan cleavage and to prevent
BAV. Although dogma states that valve cusps arise from mesenchymal cells, Aim 2 investigates the
consequence of excess Vcan on the myocardial cell lineage contributions to the developing aortic valve in
Adamts5-/-;Smad2+/- mice and other murine models of BAV. Our preliminary data show myocardial lineage
expression of Adamts5 is required to clear Vcan-rich ECM and to form the non-coronary cusp of the aortic valve.
Due to the emerging prevalence of excess Vcan in BAV, the investigation into ECM turnover will allow insight
into the molecular and cellular origins of aortic valve diseases, which may lead to therapeutic advances.

Public health relevance
Project Narrative This research will contribute to a greater understanding of the origin of aortic valve malformations including bicuspid aortic valve that can lead to disease and rupture of the major blood vessel, the aorta. There are currently no drugs that can treat valve diseases. Our approach is aimed at developing new drug targets that recognize common factors found in diseased valve tissues that contribute to tissue damage and their inability to direct blood flow to the body.